Tissue Engineering Plant-based Vascular Grafts II

Abstract
Coronary heart disease patients do not always have a saphenous vein suitable for an arterial bypass graft.
Despite advances in vascular replacement and repair, fabricating small-diameter vascular grafts with low
immunogenicity that are capable of host tissue remodeling remains a challenge. These important clinical needs
will be met by investigating heat treatment parameters for decellularized plant-based scaffolds. Recent
advancements in plant decellularization have produced cost-efficient cellulose scaffolds providing promising
alternatives for skeletal, cardiac and bone tissue engineering. We were the first to develop robust, endothelialized
vascular grafts from decellularized leatherleaf viburnum that matched mechanical properties of native blood
vessels. Our long-term goal is to tissue engineer and test a patent, non-thrombogenic vessel for engraftment
that mimics mechanical and structural properties of native vessels. By evaluating a range of heat treatment
techniques, we will improve biodegradation and reduce immunogenicity of our plant-based vascular grafts and
offer new methodologies to expand its applications within this quickly growing plant decellularization field. We
hypothesize that heat-treated plant-derived scaffolds will recapitulate the robust multi-layer structure of native
vessels and enable host tissue remodeling, with greater patency and resistance to thrombosis in vivo. We have
developed a highly innovative heat treatment disrupting lignin and hemicellulose in the cell wall, as well as
intermolecular ester bonds. Our Specific Aims are: 1) optimize plant-based vascular grafts using heat treatment
to degrade the scaffolds and inactivate harmful lectin proteins and 2) validate grafts in vivo to compare their
patency, tissue integration and biodegradation to a field standard (PTFE). An immediate goal is to remove foreign
DNA from the decellularized plant scaffold but maintain cellulose’s mechanical properties. After graft
recellularization of the endothelial and smooth muscle cells, cyclic application of fluid shear stress will be applied
to pre-condition the construct for implantation and validation in an animal model. Our preliminary tests providing
heat treatment of plant leaves in alkaline solution, combined with decellularization, improved decellularization
efficiency, degradation, and elastic modulus. Thus, we predict providing a key method for decellularizing plants
and pre-conditioning cells in a natural scaffold capable of successful engraftment.
Importantly, our proposed project will also enhance the research environment at Hofstra University by
allowing undergraduate students to plan, execute and perform analysis of authentic hands-on research that
serves a critical need in public health. The PI and his research team will provide a diverse group of undergraduate
students with a closely mentored biomedical research experience and projects that they can work on
independently. Students will prepare articles for journals and present at appropriate scientific conferences. This
will allow students to acquire a broad range of skills in biomedical engineering that they would otherwise not
have access to and is expected to have a significant impact on their future studies and career choices.

Public health relevance
Public Health Relevance Statement Bypass surgery for coronary heart disease has been shown to decrease the risk of heart attack, but many patients do not have a suitable saphenous vein, which is required to redirect blood flow around their blocked arteries. As a result, there is a growing need for synthetic, natural and hybrid polymer small-diameter vascular graft alternatives to autologous vessels. Our project will improve the performance of plant-derived materials for tissue engineering of vascular grafts with patency and mechanical properties comparable to native vessels.